Hyster (Rivas-Souchet) Diversity Supplement

Asymmetric Photoenzymatic Csp3—Csp3 Decyanative Couplings
Nitriles are present in a range of different biologically active molecules and can also serve as a synthetic
handle to other functional groups, making their facile and stereoselective assembly crucial for modern
drug development. The current methods to synthesize nitrile stereocenters are limited to Csp2–Csp3
precursors. Biocatalysis offers a unique approach to establish nitrile stereocenters with the added benefit
of directed evolution for catalyst development. We propose a novel asymmetric Csp3–Csp3 coupling to
forge tertiary nitrile stereocenter via photoenzymatic biocatalysis of malononitriles and readily available
𝛼𝛼-chloroamides. Preliminary work shows moderate to good yields and enantioselectivities of cross-
coupled product accelerated by flavin-dependent ene-reductase (ERED). The current strategy for the
continued advancement of this project is to: identify ideal conditions for the decyanative transformation,
conduct a directed evolution campaign on the most selective ERED candidate, and investigate the
underlying mechanism of this novel reactivity. This approach will allow the exploration of an enzyme-
mediated reactive intermediates that can be directed into new stereoselective assemblies.

Public health relevance
Project Narrative: The proposed project describes using ﬂavin-dependent ‘ene’-reductase (ERED) enzymes to catalyze radical-mediated transforma�ons and address selec�vity challenges through Csp3–Csp3 bond forma�on. Preliminary work shows moderate to good yields and enan�oselec�vi�es of cross-coupled product forging a nitrile stereocenter. The facile and stereoselec�ve assembly of medicinally relevant nitrile moie�es will be achieved through reac�on op�miza�on, directed evolu�on of chose enzyme, and mechanis�c inves�ga�ons.